Elucidating the Molecular Role of SYNCRIP in Prostate Cancer and AR Targeted Therapy Resistance

PROJECT SUMMARY
Prostate cancer (PCa) is the most commonly diagnosed cancer among American men and metastatic Castration-
Resistant Prostate Cancer (mCRPC) is the mostly deadly form of PCa. mCRPC is currently treated with AR
targeted therapy, however resistance to the current therapies for mCRPC is unfortunately inevitable,
underscoring the critical demand for elucidating the mechanisms of resistance and identifying actionable
therapeutic targets to overcome resistance. We have identified the loss of Synaptotagmin Binding Cytoplasmic
RNA Interacting Protein (SYNCRIP) as a top candidate conferring therapy resistance through a in vivo library
screening examining genomic alterations which confer resistance. We discovered that the frequent deletion of
SYNCRIP, occurring in approximately 14% of patients, is strongly associated with poor clinical outcomes of
mCRPC patients receiving AR targeted therapy. Our data has demonstrated that depletion of SYNCRIP
promotes resistance to AR targeted therapy both in vitro and in vivo. Mechanistically, we found significantly
upregulated APOBEC-mediated DNA mutation patterns in both PCa cell lines and mCRPC patients with
SYNCRIP depletion. The DNA deaminase APOBEC1, presumably sequestered by SYNCRIP, is required and
sufficient for the AR targeted therapy resistance observed in SYNCRIP-depleted tumor cells. Thus, the overall
objectives of this application are to define the molecular role of SYNCRIP in PCa tumorigenesis and AR targeted
therapy resistance, and to elucidate the molecular mechanisms through which the loss of this protein promotes
tumorigenesis and resistance, using human PCa cells, organoids, and mouse models. We proposed to elucidate
the role of this putative tumor suppressor gene by testing the following central hypothesis: Loss of SYNCRIP
confers resistance to AR targeted therapy through the ectopic APOBEC-mediated mutagenesis of key
oncogenes and the activation of downstream signaling pathways. We will examine this hypothesis by
pursuing three specific aims: In Aim 1, we will define whether SYNCRIP depletion promotes PCa tumorigenesis,
including both primary PCa and mCRPC, and AR targeted therapy resistance using multiple human PCa cell
lines, organoids, and xenograft models. We will also examine whether SYNCRIP depletion adjusts AR
dependency and lineage plasticity. In Aim 2, we will elucidate the role of APOBEC-mediated mutagenesis in
mediating AR targeted therapy resistance in cells with SYNCRIP depletion, and identify the mutated resistant
driver genes. In Aim 3, we will determine the role of SYNCRIP in the initiation, progression, and response to AR
targeted therapy of primary PCa using various mouse models. These proposed aims will capitalize on the
expertise of our lab and of our collaborators to comprehensively define the role of SYNCRIP in PCa
tumorigenesis and therapy resistance, and to elucidate the molecular mechanism through which the loss of this
tumor suppressor confers resistance. The completion of this study will delineate novel insights into the
mechanism of AR targeted therapy resistance and may identify new actionable therapeutic targets and
approaches to overcome resistance, thus greatly improving the clinical outcome of patients with PCa.

Public health relevance
PROJECT NARRATIVE The resistance to current AR targeted therapies is one of the biggest challenges when treating advanced prostate cancer and largely hinders the clinical outcome of patients with this deadly disease. This study aims to determine the molecular role of a new potential tumor suppressor in prostate cancer, SYNCRIP, in suppressing APOBEC- mediating mutagenesis and resistance to AR targeted therapies. Elucidating the role of this protein and the molecular mechanism of the resistance may identify new actionable targets and establish a pathway for the development of therapeutic approaches to overcome the resistance and ultimately benefit patients.